Artemisia SP and Insulin Action/William T. Cefalu

Insulin resistance is a key pattioptiysiologic feature of the

Public health relevance
RELEVANCE (See instructions): Given the paucity of data regarding safety and efficacy of botanicals, randomized trials with mechanistic aims are warranted. Before clinical studies can proceed, critical pre-clinical data addressing efficacy, safety and mechanisms are required. The studies will provide for a critical pre-clinical evaluation of botanicals to guide future studies designed to test feasible interventions for insulin resistance and metabolic syndrome.